Cell Surface Changes During the Egg-to-Embryo Transition

DESCRIPTION (provided by applicant): If fertilized, all eggs undergo an egg-to-embryo transition. Within minutes or hours of insemination, depending on the animal, the egg shuffles its existing molecular machinery and transforms itself into a cell with vastly different developmental potential. The first mechanistic alteration of this egg-to-embryo transition establishes the block to polyspermy, which is followed by and integrated with the turnover of maternal mRNA and cytoplasmic proteins, altered signal transduction capabilities, and changes at the cell surface including the addition and removal of specific membrane proteins and lipids. This transition is independent of new transcriptional activity, and for technical reasons, a majority of recent research towards understanding the egg-to-embryo transition has focused on signal transduction mechanisms and changes in mRNAs. The sea urchin and starfish, however, offer an opportunity to examine the changes that occur specifically at the cell surface. While the details of this process differ among animals, as with much of the reproductive phenomena, all eggs undergo this general transition. We will take advantage of the sea urchin and starfish because 1) millions of oocytes, eggs and embryos are readily obtained;2) all the major proteins of the cortical granules have been defined;3) the egg and oocyte plasma membrane can be manipulated experimentally in many ways;and 4) the genome sequence and genomic resources from the sea urchin Strongylocentrotus purpuratus are available. Results of this study will elucidate conserved mechanisms of this major developmental transition in all animals. Furthermore, because the changes examined here are at the cell surface, they will help clinicians develop new methods to non-invasively assess developmental potential in IVF applications for humans. PUBLIC HEALTH RELEVANCE: Immediately after fertilization, the egg rapidly transforms into an embryo with many new biochemical, cellular, and developmental features. This essential change is programmed into the egg and is independent of new gene expression;i.e., they reflect changes of the existing molecular machinery. Our research focuses on the changes that occur on the cell surface of the egg to embryo transition. These are some of the most rapid and conserved changes that occur in embryos and are detectable from the outside of the cell. Thus, this research will lead to a better understanding of a major transition in fertilization and development of all animals, and to the identification of non invasive, early markers indicative of successful development. Our results will have particular significance to clinical IVF predictions in human reproductive health.